Leadership, Planning and Evaluation

LEADERSHIP, PLANNING AND EVALUATION
PROJECT SUMMARY/ABSTRACT
Effective and proactive leadership, planning, and evaluation are essential to the success of Yale Cancer
Center’s (YCC) mission. Leadership, Planning and Evaluation (LPE) activities are instrumental in supporting
YCC’s goals of fostering the most impactful science, translating Yale science into ground-­breaking clinical
advances, developing innovative public health and prevention strategies, training the next generation of
leaders in cancer research and reducing the burden of cancer throughout our catchment area and beyond.
YCC Director, Charles Fuchs, MD, MPH, has overall responsibility for LPE and works closely with Associate
Director, Research Affairs, Robert Garofalo, PhD, who oversees the implementation and progress of the
Strategic Plan and leads the Administrative team that provides the organizational and analytical support for
LPE activities.
Dr. Fuchs benefits from input from the YCC Leadership committees, including the Mini-­Cab and Executive
Committee (EC), both of which he Chairs, and from the External Scientific Advisory Board (ESAB), the Internal
Advisory Board (IAB), the Shared Resource Oversight Committee (SROC), Membership Committee and the
Education and Training Committee (ETC). Together, the internal and external advisory, operational and
leadership committees help to maximize YCC’s success by providing in-­depth evaluation and thorough, expert
direction for all basic, translational, clinical, and population-­based programmatic areas, shared resources,
center administration, and the essential characteristics of an NCI Designated Cancer Center.
Based on recommendations from internal and external advisory groups, the YCC Director and Senior
Leadership have developed an innovative and comprehensive Strategic Plan to set the course for YCC over
the next three to five years. Outcomes of planning and evaluation activities over the last funding period
included numerous strategic and operational decisions made by Senior Leadership, as represented in the
Director’s Mini-­Cabinet (Mini-­Cab) and Executive Committee, during the funding period that advanced multiple
aspects of our plan to propel the Center’s mission forward. These include: increasing translational activity in all
Research Programs through new internal grant programs;; key recruitments and collaborations;; developing the
Translational Immuno-­Oncology Laboratory (TIL);; reorganizing our Biostatistics Shared Resource;; establishing
the Translational Research Core Committee charged with developing infrastructure to enhance research
access to clinical genomic information and biospecimens;; recruitment of Cancer Biology Institute faculty and
physician-­scientists;; generating new institutional support to enhance key shared resource initiatives;;
reorganizing Clinical Trials Office procedures to improve activation times;; launching the Diversity and Health
Equity (D&HE) team to promote community outreach and engagement;; and establishing an Education
Committee led by a newly-­appointed Associate Director for Education, Training and Faculty Development.